Cell Signaling in Cancer- From Mechanisms to Therapy

PROJECT SUMMARY ABSTRACT
Decades of research has revealed the complexity of cellular signaling networks involved in control of cellular
processes and their exceptional vulnerability as target of dysregulation in many disease states, like cancer.
During the multistep process of tumor initiation and progression, cancer cells acquire unique capabilities termed
the “hallmarks cancer” that include: a) sustained proliferation in the absence of growth-promoting signals, b)
evasion of growth-inhibitory signals, c) activation of invasion and metastasis, d) enabled replicative immortality,
e) induction of angiogenesis, and f) resistance to cell death. Unsurprisingly, aberrant activation or inactivation of
signaling pathway components, which typically integrate extrinsic or intrinsic cues to guide cell division, growth,
and migration, is a defining feature of malignant cells. Decades of research aimed at unraveling the complexity
of cellular signaling networks in the context of cancer has revealed many of the principles of intracellular
communication essential for normal physiology and ushered in the era of targeted therapeutics for cancer
treatment. While small molecular inhibitors that target signal transducers have been clinically efficacious, several
challenges, such as emergence of resistance, tumor cell heterogeneity, and undruggable targets, has limited the
widespread use of these agents in cancer. There are three specific objectives of the FASEB 2024 Cell Signaling
in Cancer: from Mechanisms to Therapy. The first objective is to disseminate and synthesize the most up-to-
date knowledge and newest technologies surrounding mechanisms and therapeutic targeting of cancer cell
signaling pathways. To accomplish this goal, we have planned a series of keynote and plenary speakers from
many of the leading experts in the field, multiple short talks selected from the poster abstracts, poster sessions,
several focused workshops, and informal discussions. Since the challenges in this field are daunting and will
require collaborative efforts to solve them, the second objective is to enhance interactions between academia,
industry, and clinical science. To this end, we have specifically invited speakers representing each of these
topics, and are planning a workshop to discuss career trajectories in different disciplines and navigating
productive collaborations. The third objective is to invest intellectually and financially in the future by supporting
promising young trainees. The goal is to encourage trainees to be successful and stay in the field by providing
intellectual support through discussions with senior scientists, poster sessions, opportunities to speak, awards
that recognize their achievements, and by providing financial support with competitive travel awards. To
specifically increase opportunities for trainees, we have planned a designated Junior Scientist Symposium at the
start of the meeting including a Keynote Presentation from a Junior Investigator, Christina Towers from the Salk
Institute which will give trainees more opportunities to present and discuss their work. The expected outcomes
are increased collaborations, promotion and training of young scientists in the field, identification of new
approaches for identifying and developing therapeutic targets and strategies to combat cancer.

Public health relevance
PROJECT NARRATIVE This application requests partial support for the 2024 FASEB Summer Research Conference on Cell Signaling in Cancer: from Mechanisms to Therapy, which is focused on the genetic, molecular, and biochemical mechanisms of cellular signal transduction in malignant transformation and proof-of-concept or clinically tractable means to translate these discoveries. Both basic/translational scientists and clinicians at this conference will be exposed to the emerging concepts in the cancer cell signaling field, including but not limited to including but not limited to Structure and Function of Signaling Complexes, Signaling in Space and Time in Cancer, Systems Biology and Proteomics, Nutrient Signaling and Metabolic Processes, Tumor Microenvironment, Modeling of Cancer and Chemical Biology. Together, participants will be encouraged to explore deeper mechanistic understanding of the contribution of dysfunctional cellular signaling networks to tumor initiation and progression, which was critical for the translation of drugs used clinically today, with the long-term goal of bringing precision medicine to cancer patients.